Safeguards of the Proteome: Elucidating the Roles of Protein Disaggregases

Abstract:
The proper folding of proteins is essential for all life, making aberrant protein folding severely problematic. The
protein homeostasis (proteostasis) network is a tightly regulated system that ensures that proteins are folded
and degraded as necessary. However, misfolded proteins can overwhelm the proteostasis network. Protein
misfolding is associated with numerous devastating neurodegenerative and cardiovascular disorders. Protein
disaggregases can engage misfolded substrates and unfold them, promoting their return to proper fold and
function. Disaggregases may serve as the final defense against collapse of the proteostasis network.
Disaggregases play key roles in maintaining cellular health, and can even regulate beneficial amyloids in
yeast. Amyloid is an exceptionally stable protein conformation that is implicated in numerous human diseases,
and amyloid is considered to be otherwise intractable. I hypothesize that disaggregases play key roles in
maintaining cellular health, but are vulnerable when the proteostasis network becomes overwhelmed in
disease. Therefore, technologies that modulate disaggregase activity might be therapeutically useful. However,
protein disaggregases are the least well characterized branch of the proteostasis network. I envision building a
research program focused on developing a more comprehensive understanding of how disaggregases counter
misfolding, both in health and under stress. I seek to elucidate how cells maintain proteostasis, how
proteostasis fails, and how protein disaggregases might ultimately be applied to prevent or even reverse
collapse of proteostasis. To further these goals, we will focus on three main themes over the next five years:
(1) we will develop and apply new technologies to study and modulate the substrate-specificity of Hsp104,
which regulates beneficial amyloid conformers in yeast. (2) We will characterize newly identified human
amyloid disaggregases to better understand their normal roles in maintaining cellular health and how they
might fail in disease. (3) We will apply new mass spectrometry techniques to study how protein-remodeling
factors select specific substrates to target and how this varies under stress conditions. Our work will elucidate
how disaggregases target specific substrates. Additionally, these finely-tuned disaggregases can be used as
probes to test the hypothesis that misfolded species are toxic, and that restoration of proteins to their native
folds and functions can reverse disease phenotypes. Ultimately we aim to apply the findings from these studies
to develop new strategies to treat neurodegenerative disease. This is especially important because, despite
intense efforts, there are no therapeutics available to treat protein-misfolding disorders.

Public health relevance
Narrative: Protein misfolding is associated with numerous devastating neurodegenerative and cardiovascular disorders. We seek to understand the role of protein disaggregases, which can solubilize misfolded proteins and restore the proteins to their native folds and functions. We seek to better understand how these agents maintain cellular health and how they counter cellular stress, because with this understanding we might gain new insights into how they fail in disease, ultimately leading to new insights into how disaggregases can be modulated to develop new therapeutics.